Maintenance and Improvement of NINDS Infrastructure

The following laboratories and research support areas underwent planning, modification, relocation, or renovations during FY 2023:
1. Stroke Branch laboratories, Location NIH Bethesda Campus, Bldg 10.
2. NINDS Biospecimen Core Facility, Location: NIH Bethesda Campus, Bldg 8.
3. Cell Biology and Biophysics Section. Location: NIH Bethesda Campus, Bldg 35.
4. Clinical Trials Unit. Location: NIH Bethesda Campus, Bldg 10.
5. Neuroimmology office cluster. Location: NIH Bethesda Campus, Bldg. 10.
6. Renovations and equipment modifications in the Vivarium; Location: NIH Bethesda Campus, Bldg 35.
7. Surgical Neurology Branch laboratories. Location: NIH Bethesda Campus, Bldg 10.
8. Back-up cooling system for NINDS Server Room. Location Bethesda Campus, Bldg 35.
9. NINDS CRYO EM Core. Location NIH Bethesda Campus, Bldg 35A.
10. Replacement of Porter Phase I RO Water system. Location: NIH Bethesda Campus, Bldg 35.
11. MRI siting evaluation. Location: Bethesda Campus. Bldg 10.
12. Interoceptive Disorders Unit of the Office of the Clinical Director, in Bldg 10. Location: NIH Bethesda Campus, Bldg 10
13. Synaptic Function Section laboratory. Location: NIH Bethesda Campus, Bldg 35.
14. Neurodegenerative Diseases Research Unit laboratory, Neurogenetics Branch. Location: NIH Bethesda Campus, Bldg 35.
15. Neocortex-cerebellum Circuitry Unit laboratory. Location: NIH Bethesda Campus, Bldg 49.
16. Shared research facilities, Location: NIH Bethesda Campus, Bldg 49.
17. Multi-IC Instrumentation Shop. Location: NIH Bethesda Campus, Bldg 13.
18. Inherited Moverment Disorder Unit, Neurogenetics Branch (NGB). Location: NIH Bethesda Campus, Bldg 35.

Porter Neuroscience Building 35A experienced a catastrophic flood in December 2023 which resulted in multimillion dollar loss of major scientific equipment and staff time. The impact of this event on FY23 budget is reflected in this annual report.